COBRE in Human Genetics

Project Summary
Iron deficiency is the single most common nutrient deficiency in the world impacting one-third of the world’s
population. Recent analysis of the US National Health and Nutrition Examination Survey (NHANES) and
Supplemental Nutrition Program for Women, Infants, and Children (WIC) data established dietary iron intakes
are decreasing in the US population and the decline parallels increasing rates of anemia. Increases in iron
deficiency may be caused by declining diet quality and/or high rates of nutrition and food insecurity. Iron
deficiency is the leading cause of anemia which severely impacts physical and cognitive development, work
capacity, and leads to poor health outcomes. The WHO categorizes iron-deficiency anemia as hemoglobin levels
<120 mg/dL (non-pregnant females) and iron deficiency as ferritin levels <15 ng/mL in individuals over 5 years
old and <12 ng/mL in children under 5 years old. These ferritin levels, which are used clinically, are not agreed
upon. First, a level of 30 ng/mL has been suggested to have 92% sensitivity and 98% specificity for correlating
iron deficiency with the absence of iron stores in the bone marrow. Second, marginal iron depletion (normal
hemoglobin levels with inadequate ferritin stores, defined as ferritin levels between 15-30 ng/mL) is suggested
to impair cellular functions. In human studies, individuals with marginal iron depletion have reduced physical
work capacity, yet their ability to transport oxygen is not impaired. This indicates other pathways involved in
physical work capacity may be compromised, yet these cellular pathways and their mechanisms have yet to be
determined. Furthermore, the correlation between iron-dependent tissues and cellular compartments, blood
biomarkers of iron levels, and the cellular pathways that lead to reduced work capacity have not been
determined. Our preliminary data indicate that impairing iron status from mild to severe depletion in mouse
myoblast cells reduces cellular respiration and the contribution of ATP from mitochondrial oxidative
phosphorylation before the cellular biomarker (transferrin receptor) for iron deficiency responds. Our overall
objectives in this application are to 1) establish the relationship between blood values of ferritin and hemoglobin
with tissue and cellular compartment levels of iron, and 2) determine the relationship between iron status and
iron-dependent mitochondrial and cellular functional declines. Our central hypothesis is that (1) certain tissues
and cellular compartments are more susceptible to iron loss and deplete at different rates, occurring before blood
biomarkers/levels of iron decline, and (2) mitochondrial function is compromised with marginal iron depletion and
is an underlying cause of skeletal muscle reduced work capacity. We will test this hypothesis in two specific
aims. In the first aim, we will use an established mouse model and dietary iron intervention to alter iron status to
determine the association between commonly used blood biomarkers of iron status, tissue and cellular
compartment levels of iron status, and sex differences in iron distribution as a result of mild to severe iron
depletion. In the second aim, we will extend our studies in these models to determine the causes and
contributions of iron depletion related to mitochondrial ETC complex activity and mitochondrial substrate
utilization, both of which directly affect mitochondrial energy production capacity. This proposal is innovative in
concept and approach and will inform on safe and effective nutritional strategies for maintenance of iron levels
to maintain optimal mitochondrial function.
1

Public health relevance
Project Narrative The proposed research will establish the relationship between blood, liver, and skeletal muscle levels of iron, the onset of cellular declines, and the mechanistic pathway(s) that lead to a reduction in the work capacity across iron levels. The work is relevant to public health and the NIH mission because iron deficiency is the most common micronutrient deficiency in the world, is common in life stages including women of reproductive age and children, and may contribute to skeletal muscle impairment before iron biomarkers are compromised.